Neoantigen-specific Adoptive T Cell Therapy for Glioblastoma, IND-BB-13135, protocol submitted 04/25/2020

TVAX Biomedical has developed a novel form of immunotherapy, neoantigen-specific adoptive
T cell therapy (NACT), that has the potential to significantly improve outcomes for newly
diagnosed glioblastoma patients. There is a significant unmet medical need for safer, more effective
treatments for glioblastoma. Surgery combined with temozolomide chemoradiotherapy provides modest
survival benefit and is not curative. Moreover, the O6-methylguanine methyltransferase negative (MGMT
unmethylated) subgroup, which is comprised by approximately 60% of glioblastoma patients, is relatively
resistant to the temozolomide component of chemoradiotherapy. NACT combines 1) neoantigen-specific cancer
cell/immunological adjuvant vaccination, 2) adoptive transfer of ex vivo-activated cancer neoantigen-specific
effector T cells and 3) interleukin 2 to produce a treatment that has the potential to be effective against surgically
resectable glioblastomas. As an autologous immunotherapy, NACT generates only transient (24-72 hours) grade
1 and 2 toxicity. The patients’ own cancer cells are combined into a vaccine with a strong immunological adjuvant
(granulocyte macrophage colony-stimulating factor) to produce a polyclonal cancer neoantigen-specific immune
response that significantly increases the number of cancer neoantigen-specific effector T cell precursors in the
patient’s body. These cancer neoantigen-specific T cells can be harvested from the blood and stimulated ex vivo
with T cell activating agents. The result is the generation of high numbers of cancer neoantigen-specific effector
T cells that have the ability to orchestrate effective cancer cell killing following their return to the patient’s body.
NACT is most effective when the patient has a healthy immune system and minimal disease. This randomized
50-subject study is designed to compare the combination of NACT and standard therapy to standard therapy
alone as a treatment for newly diagnosed MGMT unmethylated glioblastoma patients. Immunotherapy would
be maximal when used to treat patients with relatively healthy immune systems and disease that has been
reduced by standard chemoradiotherapy. Benefit may also accrue from standard therapy’s reduction or reversal
of immunosuppression. Success is anticipated because preclinical glioma studies and previous phase 1/2a clinical
studies with recurrent high-grade astrocytoma patients who had failed surgery, radiotherapy and chemotherapy
provided evidence that NACT is safe and effective and could be curative. This phase 2b clinical trial will be
performed in collaboration with the neuro-oncology and neurosurgical team in the Division of Medical Oncology
- Neuro-Oncology, Department of Medicine at the Rutgers Cancer Institute of New Jersey. Success in this clinical
trial will lead to performance of a larger phase 2/3 clinical trial designed to generate data that could lead to
marketing approval by the FDA and subsequent commercialization of NACT as a treatment for MGMT
unmethylated glioblastoma. This will be the first time that this treatment will have been tested for safety,
efficacy, and immunological effects in patients with newly diagnosed MGMT unmethylated glioblastoma.

Public health relevance
TVAX Biomedical is performing clinical testing of a novel cancer immunotherapy, neoantigen-specific adoptive T cell therapy (NACT), that makes use of the patient’s own immune system to combat their cancer. Prior human studies have demonstrated NACT to be a safe and effective treatment for multiple cancers. This randomized 50-subject clinical trial’s goal is to compare the safety and efficacy of NACT in combination with standard therapy compared to standard therapy alone as treatments for newly diagnosed glioblastoma, a disease for which there currently are no safe and effective treatments.